Maternal Marijuana Use During Pregnancy, Marijuana Legalization, and Adverse Obstetrical and Neonatal Outcomes: A 12-year Cohort Study

PROJECT SUMMARY/ABSTRACT
Prenatal marijuana use is increasingly recognized as an important public health problem that could have a
large scale negative impact on maternal, fetal and neonatal health. We propose a retrospective and
prospective longitudinal cohort study of over 400,000 pregnancies screened for prenatal marijuana use based
on gold standard self-reported and urine toxicology data from 2009 to 2020, leveraging Kaiser Permanente
Northern California’s universal prenatal substance use screening program that is part of standard prenatal
care. We will assess associations between maternal marijuana use during pregnancy and key maternal, fetal
and neonatal outcomes, controlling for potential confounders (e.g., tobacco use, alcohol and other drug
exposure, income) and comparing exposure across trimesters. These analyses also take advantage of a
unique natural experiment and will examine whether California state marijuana legalization in 2018 and local
regulatory practices (e.g., retailer bans, prominent warnings on marijuana use during pregnancy) are
associated with variation in marijuana use during pregnancy. With high generalizability and a sample size
unmatched by any other study on this topic, results from each aim have direct implications for the care of
pregnant women while providing novel insight to drive future epidemiological and clinical trial-based
intervention studies. Aims 1 and 2 will provide generalizable and comprehensive data to understand the health
impact of prenatal marijuana use on mothers and their babies. Aim 3 will allow us to identify changing trends in
prenatal marijuana use following marijuana legalization and will inform clinicians, researchers, and policy
makers of the future scope of the problem. Finally, the study cohort will be a valuable resource for future
research on the long-term impact of prenatal marijuana use on maternal and children’s well-being.

Public health relevance
PUBLIC HEALTH RELEVANCE Despite widespread and increasing use of marijuana during pregnancy in the US, we know little about how prenatal marijuana exposure affects maternal, fetal, and neonatal outcomes. This large longitudinal cohort study of >400,000 pregnancies screened for prenatal marijuana use via self-report and urine toxicology data from 2009 to 2020 examines whether prenatal marijuana use is associated with increased risk of adverse maternal, fetal, and neonatal outcomes, and tests whether prenatal marijuana use rises after recreational marijuana legalization in California in 2018. Findings will have immediate public health and clinical implications, providing policy makers, clinicians, and patients with critical data on the health effects of prenatal marijuana use and the impact of legalization that can inform policy, treatment and education programs to minimize the risks of prenatal marijuana exposure.